The Alzheimer's Disease Research Center at the University of California, Irvine

PROJECT SUMMARY/ABSTRACT – OVERALL
The theme of University of California Irvine Alzheimer’s Disease Research Center (UCI ADRC) is accelerating
discovery in Alzheimer’s disease (AD) and AD Related Disorders (ADRD) research across special populations.
The UCI ADRC plays a distinctive role in the ADRC network, with a rich history of studying unique groups that
have been underrepresented in AD/ADRD research. We have been a leader in research on individuals 90 years
and older and our center was one of the first to study participants with Down syndrome (DS), groups at increased
risk for dementia but often excluded from research. We have focused strongly on the underrepresented but
rapidly growing populations of older Asian American and Hispanic individuals and have helped establish the first
national registry of Asian American individuals to support inclusion in AD/ADRD research. We ensure data from
these populations are available to the entire ADRC network through our Clinical Core, which emphasizes the
earliest signs of disease, including mild behavioral impairment; and our unique special population DS Core and
Oldest-Old Core. These invaluable resources synergize with our six other ADRC cores and our Research
Education Component in a center that is highly collaborative. Our Neuropathology Core has shared tissue from
>1500 donated brains with >120 investigators worldwide. Our induced Pluripotent Stem Cell Core was the first
of its kind in the ADRC network and has shared iPSCs with >70 laboratories worldwide and supported more than
$125M in NIH-funded projects. Our Data Management and Statistical Core supports ADRC investigators through
applied research and develops improved statistical methods. Our Biomarker Core implements state-of-the-art
tools while researching ways to make biomarker information more accessible. Our Outreach Recruitment and
Engagement Core has strong ties to the diverse local community and is a leader in the science of recruitment.
The Administrative Core of UCI ADRC has consistently provided strategic leadership to ensure that our center
constantly innovates, collaborates, and educates.

Public health relevance
PROJECT NARRATIVE – OVERALL Alzheimer’s disease (AD) and AD Related Disorders (ADRD) are public health crises that require discovery of solutions through research. Orange County California is an epicenter for this crisis and the University of California Irvine Alzheimer’s Disease Research Center (UCI ADRC) is strategically located to have a major positive impact as we accelerate discovery in AD/ADRD research across special populations. The UCI ADRC brings innovative, multi-disciplinary, collaborative approaches toward this effort; as well as a strong focus and key resources toward the inclusion of special populations often underrepresented in research such as adults with Down syndrome, people from Asian American and Hispanic communities, and the oldest-old.